PRSS1 Mutation and Pancreatic Cancer Tumorigenesis

Abstract:
The 5-year relative survival of pancreatic ductal adenocarcinoma (PDA) patients is only 8%. PDA is
predicted to be the second-leading cause of cancer related death in the U.S. by 2030. Understanding the key
signaling mechanisms of tumorigenesis is critical for developing life-saving interventions. Hereditary
pancreatitis (HP), an autosomal-dominant disorder with recurrent episodes of acute pancreatitis (AP) which
eventually develops into chronic pancreatitis (CP), has a cumulative risk of pancreatic cancer of 44% by age
70 years. Cationic trypsinogen gene (or PRSS1) mutations are the most common causes of HP. Unfortunately,
the development of targeted preventive or therapeutic interventions for HP has been hampered by gaps in our
understanding of its pathophysiology, which is mainly due to the practical difficulties in obtaining tissues from
human pancreas at early stages of the disease and the lack of animal models that recapitulate the human form
of this disease. Recently we have developed a novel model of HP by expressing a common mutant of human
PRSS1 (PRSS1R122H) in mice (J Clin Invest. 2020 Jan 2;130(1):189-202). Transgenic expression of mutant
PRSS1 caused severe AP which progresses to CP, precancerous PanIN lesions, and pancreatic cancer. This
model of HP will provide us with a powerful tool to fulfill our long-term goal of understanding the initiating
events of HP and developing specific strategies to prevent its progression to pancreatic cancer. In this
proposal, we will use our unique humanized pancreatitis model to test our central hypothesis that etiological
factors and PRSS1 gene mutation cooperatively cause pancreatic tumorigenesis by intra-acinar cell stress
signaling pathways and a trypsin receptor-mediated constant inflammatory milieu. We will characterize these
signaling pathways in this newly developed HP model and investigate their roles in pancreatic cancer
tumorigenesis by both pharmacological and genetic approaches. We expect these studies will significantly
improve our understanding of the pathogenesis of HP, its progression to pancreatic cancer, and provide new
insights for developing/testing novel preventive and therapeutic interventions.

Public health relevance
Project Narrative: PRSS1 mutations cause human hereditary pancreatitis with high risk of developing to pancreatic cancer. We developed a novel mouse model by expressing a mutant human PRSS1 to study the mechanisms of pancreatic cancer tumorigenesis. We expect these studies will significantly improve our understanding of this disease and provide new insights on interventions.